Role of TIM Molecules in Regulatory and Inflammatory B cells in Allo andAutoimmunity

In addition to humoral immunity, B cells play an important role shaping T effector responses through antigen
presentation, costimulation, and cytokine production. Thus, B cell depletion ameliorates autoimmune diabetes
and arthritis in mice, and rapidly improves RA and MS in humans, and outcomes do not correlate with fall in
autoantibodies. In contrast, in both humans and mice, B cell depletion can also worsen autoimmunity, and can
promote acute rejection and chronic vasculopathy in renal and cardiac transplant patients, respectively. These
studies indicate that B cells can either enhance, or inhibit, inflammatory responses. In this regard, transfer of
various B cell subsets can inhibit autoimmunity and allograft rejection through IL-10, and a growing list of other
mechanisms. However, lack of a universal phenotype or master transcription factor (TF) for these Bregs has
stymied the field. It is unknown whether these disparate cells are distinct or inter-related, or what regulates
their differentiation or cytokine expression. Our preliminary data show that: 1) TIM-1 is an inclusive marker for
IL-10+ Bregs. 2) Intact TIM-1 signaling on B cells regulates the expression of both TFs and various regulatory
molecules (“regulatory module”). This allows us to test their role in Breg differentiation and function. 3) We also
show that CpG-activated Pro-B cells transfer exceeding potent suppression, mediated by mature Breg progeny
exhibiting different mechanisms of action in different locations. Both progenitors and progeny are TIM-1+,
which allows us to examine the role of TIM-1 and TFs in Breg differentiation and regulatory module expression.
B cells can also express various proinflammatory cytokines in autoimmune and infectious settings that
strongly promote inflammatory responses. No phenotype for such effector B cells (Beff) has been established,
and it is unclear whether the various cells described, are distinct or inter-related. Major aspects of Beff biology
are completely unknown, including how differentiation and cytokine expression are regulated. We have
discovered that: 1) TIM-4 identifies Beff that express IFNγ and IL-17 and accelerate allograft rejection. 2) IL-17
is notably, both a potent effector cytokine, and is also required for development of the Beff inflammatory
program. Loss of B cell IL-17 not only reverses their inflammatory role, but also, inhibits the immune response,
promoting allograft tolerance. 3) TIM-4 ligation inhibits proinflammatory cytokine expression.
Based on our novel preliminary data, this PPG will utilize autoimmune and allograft models to test the
central hypothesis that TIM-1 and TIM-4, respectively, are unifying markers for Bregs and Beff and regulate
expression of TFs and other molecules important for their development and function. This will be addressed in
3 interactive and mutually supportive projects: Project 1: Role of Tim-1 and Bregs in Tolerance and Auto-
immunity; Project 2: Immunoregulation by TLR-activated TIM-1+ ProB Cells in Transplantation; and Project 3:
Inflammatory B Cells Defined by TIM-4 in the Alloimmune Response. This understanding is key to developing
clinically relevant approaches to selectively target Beff and Bregs to enhance or inhibit the immune response.

Public health relevance
B cells can profoundly influence the immune response by expressing cytokines that either promote (effector B cells) or inhibit (regulatory B cells) transplant rejection and autoimmunity. However, factors regulating the development and function of these B cells are poorly understood, and there is no unifying approach towards their identification or manipulating their activity. We find that TIM-1 identifies regulatory B cells that express an array of regulatory molecules. Moreover, TIM-4 identifies effector B cells that express various inflammatory mediators. This proposal will determine what regulates the development and function of these B cell subsets, and identify their mechanisms of action. Results of these studies will provide critical new insight necessary to manipulate the activity of both regulatory and effector B cells to promote transplant survival and inhibit autoimmunity.